Biostatistics Core

This core provides centralized services to the program project in three related areas: biostatistics, research computing, and data collection. The biostatisticians collaborate in all phases of research from study design, through interim analysis and monitoring, to final analysis and manuscript preparation. Biostatisticians were co-authors on over 140 manuscripts during the previous funding period, and are integral parts of the protocol development and review process. The computing group is responsible for the maintenance and operation of shared computing systems. These include a cluster that supports the master patient database, and two Sun workstations that support statistical computing and electronic interfaces to the database. The computing staff create and maintain entry and reporting programs for the database, assist others in data extraction from the database, and maintain electronic connections to laboratory information that is downloaded directly to the database. The data collection group is responsible for data abstraction and entry into the master patient database, and for maintenance of archival research files, which are now stored in a web-accessible optical image library (OWL). The staff follow an explicit protocol for data abstraction, coding, keyentry, and quality control, which is applied uniformly to all transplant recipients entering research protocols of the Clinical Research Division, of whom a large majority enter protocols supported by this program project.

Public health relevance
Relevance to Public Health: This core helps to design and analyze clinical research studies. It supports the collection of data from patients enrolled in these studies, and makes these data available in a computer database. This work contributes directly to the overall goals of this grant to make allogeneic hematopoietic cell transplantation safer, more effective, increasingly available and more appropriately applied.